Core--

The objective of the Administrative Resource is to provide centralized scientific & administrative management, financial control services and clerical and materials management support to all Projects and Resources. The Administrative Resourcewill provide necessary support for the organization and conduct of the Steering Committee Meetings, the annual meetings of the External Advisory Board and ongoing administration of the overall grant. The Resource will also provide web support for communication and data sharing between consortium members.